Heparan sulfate proteoglycans in signaling and development

Project Summary
The long-term goal of our research is to understand fundamental principles of cell communications
mediated by heparan sulfate proteoglycans (HSPGs). HSPGs are a special type of carbohydrate-modified
proteins that serve as co-receptors for various growth factors, including bone morphogenetic proteins,
Wnt/Wingless, and Hedgehog. These HSPG co-receptors play critical roles in quantitative and robust
control of signaling output. We study in vivo functions of HSPGs using the Drosophila model. Our earlier
research has established critical roles of HSPGs in development, namely in morphogen signaling and
gradient formation. In addition, we have demonstrated that HSPGs regulate the stem cell niche as a
universal factor. Although proteoglycan biology has made significant progress, several major questions still
remain to be elucidated. For example, the molecular mechanisms of co-receptor activities of HSPGs are
poorly understood. It is also unknown how distinct HS structures regulate specific signaling and patterning
events. It is now critical to develop an interdisciplinary approach, which can directly link detailed HS
structural motifs, ligand binding, quantitative signaling output, and developmental/physiological phenotypes.
Our previous studies suggested that HSPGs cooperate with other factors to exert co-receptor
activity on the cell surface. To reveal the molecular basis for co-receptor function, we use proteomic and
genetic approaches to identify these missing players. We recently found that Windpipe (Wdp), a
transmembrane protein containing four leucine-rich repeats, acts as a novel negative co-receptor for Hh
signaling. We also showed that Wdp is a chondroitin sulfate proteoglycan (CSPG). Thus, the Hh pathway is
controlled by two classes of proteoglycan co-receptors: HSPGs (positive regulators) and Wdp (CSPG, a
negative regulator). We will elucidate how such a "dual PG co-receptor system" achieves quantitatively
controlled signaling output and precise pattern formation.
To understand how a change in HS structure affects signaling and morphogenesis, we will establish
an "in vitro" model using Drosophila cells. Despite the many strengths of the Drosophila model for in vivo
studies, information on Drosophila HS structure is limited. This is mainly due to the difficulty of metabolic
radio-labeling of HS in vivo using Drosophila animals. To fill this gap, we have recently generated novel
Drosophila cell lines mutant for five HS modifying enzymes. Our studies using these cell lines will provide a
direct link between detailed structural information of Drosophila HS and a wealth of knowledge on biological
phenotypic information obtained over the last two decades using this animal model.
Together, this application will advance our field by: (1) defining fundamental molecular mechanisms
of co-receptor function and (2) comprehensive understanding of the structure-function relationship of HS.

Public health relevance
Project Narrative Heparan sulfate proteoglycans (HSPGs) are a special type of carbohydrate-modified proteins that serve as co- receptors for various growth factors, including bone morphogenetic proteins, Wnt/Wingless, and Hedgehog. The long-term goal of our research is to understand fundamental principles of cell communications mediated by HSPGs using the genetically tractable model organism Drosophila. In particular, we will focus on (1) defining fundamental molecular mechanisms of co-receptor function and (2) comprehensive understanding of the structure-function relationship of HS.